Augmenting host innate immune responses against Staphylococcal osteomyelitis with antimicrobial nucleic acid structures

PROJECT SUMMARY
Staphylococcus aureus is the principle causative agent of osteomyelitis (OM), a severe infection of the bone
tissue that is characterized by damaging inflammation and progressive bone loss. Current
therapy
includes
surgicaldebridement of necrotic bone tissue and prolonged treatment with antibiotics.However, S. aureus
biofilm formation on bone tissue and invasion of resident bone cells limits antibiotic effectiveness and provides
a protective niche for viable bacteria. Additionally, there is anincreased incidence of OM infectionsin part to
the emergence of antibiotic resistant strains such as MRSA that account for one-third of S. aureus isolates.
Collectively,these factors contribute torecurrent and persistent infections in 40% of patients. Therefore,
development of novel treatment strategies is a high priority. It is now appreciated that resident bone cells
including osteoblasts, osteocytes, and osteoclasts express a variety of pattern recognition receptors (PRRs) for
identification of pathogens and initiation of immune responses. We have recently published the first
demonstration of increased type I IFN production in infected femurs compared to the contralateral controls in
an in vivo model of localized Staphylococcus osteomyelitis. Our pioneering studies demonstrated that murine
osteoblasts produce significant increases in type I IFNs following S. aureus challenge and such production
serves to limit intracellular S. aureus burden. Our other recent studies also indicate that the type I IFN, IFN-β
functions as an antimicrobial peptide with bactericidal activity against S. aureus. Furthermore, resident bone
cells release antimicrobial peptides, including β-defensins in response to S. aureus challenge that possess
direct bactericidal activity, inhibit biofilm formation, and disrupt established biofilms. Collectively, this supports a
protective role for resident bone cell production of antimicrobial peptides and type I IFNs during Staphylococcal
OM and suggests augmentation of such responses is an attractive therapeutic target. In this high-risk high-
reward R21 project, we will investigate the hypothesis that augmenting protective bone cell innate immune
responses can restrict S. aureus burden by employing immunomodulatory and antimicrobial nucleic acid
structures (IMANAS). We will design IMANAS to act as effective agonists for the cytosolic PRR, cyclic GMP-
AMP synthase (cGAS) to augment protective antimicrobial peptides and type I IFN production that can restrict
bacterial burden. Additionally, IMANAS will incorporate nanostructured silver that can kill bacteria via multiple
mechanisms such as disruption of bacterial cell membrane, induction of DNA/RNA damage, generation of
reactive oxygen species, and involvement in destabilizing proteins. This high-risk high-reward R21 is
anticipated to demonstrate the efficacy of augmenting protective host innate immune responses as a strategy
to restrict bacterial burden in isolated primary murine bone cells and in an established in vivo murine model of
Staphylococcus OM. Furthermore, these studies represent an essential preclinical step in establishing the
efficacy of these innovative IMANAS to combat bacterial infections including OM.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is the principle causative agent of osteomyelitis, a severe infection of the bone tissue that causes significant morbidity due to damaging inflammation and progressive bone loss. Staphylococcus osteomyelitis is often refractory to antibiotic treatment and surgical debridement of necrotic tissue due to extracellular biofilm formation and survival inside resident bone cells. In this high-risk high-reward R21 project, we will augment host innate immune responses to restrict bacterial burden by employing immunomodulatory and antimicrobial nucleic acid structures.